FREE FATTY ACID REGULATION OF INTRACELLULAR GLUCOSE METABOLISM

To determine whether in humans, free fatty acids reduce intracellular glucose metabolism by inhibiting pyruvate dehydrogenase, phosphofructokinase and glycogen synthase.